Improving decision-making in patients with resectable melanoma and pre-existing autoimmune disease considering immune checkpoint inhibition

PROJECT ABSTRACT
Shared decision-making is a process aimed at helping health care providers and their patients make informed
health decisions. During this process, information is exchanged (patients inform doctors about their health issues
and preferences and health care providers inform patients about options for treatment), and options that will
ultimately lead to a decision regarding management are clarified. Regarding cancer treatment decisions, patients
often have other comorbidities, which can result in increased treatment-related toxicity or decreased benefits
because of competing risk of other diseases. These concerns make decision-making both emotionally and
cognitively difficult. One such difficult decision is whether to use immunotherapy as adjuvant therapy—
specifically, immune checkpoint inhibitors—in patients with resectable melanoma and pre-existing autoimmune
disease. Checkpoint inhibitors can cause adverse events due to immune-mediated tissue damage, termed
immune-related adverse events. In patients with cancer and pre-existing autoimmune disease, immune
checkpoint inhibition is possible but is associated with an increase incidence of adverse events and flares. Thus,
this treatment requires cautious monitoring.
Optimal treatment decisions require careful consideration of harms and benefits as well as the likelihood of
recurrence. The overall goal of this proposed study is to develop and test an individualized shared decision-
making tool for patients with resectable melanoma and pre-existing autoimmune disease that can be used with
providers to improve the decision-making regarding initiation of adjuvant treatment with immune checkpoint
inhibitors. Such tools have yet to be developed.
This career development award will provide the principal investigator with protected time to become a decision
scientist with an interest in shared decision-making by patients with cancer and comorbid conditions. The specific
aims of her research proposal are to evaluate the benefits and risks of immune checkpoint inhibitors in patients
with resectable melanoma and pre-existing autoimmune disease considering stage, survival, expected rates of
toxicity, and flares; 2) to develop a multicomponent shared decision-making tool for cancer patients with RA
considering treatment with immune checkpoint inhibitors; and 3) evaluate the tool which will be appropriate for
low-literacy populations, and will be tailored to patients' individual characteristics. To achieve her career goals,
the principal investigator has assembled a multidisciplinary team of experts in the fields of interest and is
proposing a comprehensive training program.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE Patients with melanoma who have a pre-existing autoimmune disease must make complex decisions with their treating physicians about the best treatment options. We propose to provide them with information presented in a user-friendly format to improve treatment decision-making and outcomes.